Project 3 Zha

PROJECT SUMMARY/ABSTRACT (<31 LINES)
Genomic instability is a hallmark of human cancers. Both ATM and BRCA1 (Project 1) are ubiquitously
expressed tumor suppressor genes implicated in DNA double strand break (DSB) repair. Yet, their losses cause
very different types of cancers – predominantly lymphomas in ATM-deficiency, and breast or ovarian cancers in
BRCA1-deficiency (Project 1). The causes for such tissue-specific malignancy risk are not fully understood.
Sequence analyses of human cancers identified a unique substitution and rearrangement signatures, some of
which (e.g. substitution signature 3 and short tandem duplications) have been linked to BRCA1 deficiency. ATM-
loss has not been linked to any signature, in part due to the low frequency (2-8%) ATM-inactivation in many
cancer types. As such, the ATM-loss signatures is concealed by tissue-specific genomic signatures and the
heterogeneity of human genomes. Here we use inbred mouse models (identical genome) to uncover ATM-loss
associated substitution and rearrangement signatures in lymphocytes (uniform cell type) and use the High
Throughput Genomic Translocation Sequencing (HTGTS) to examine lymphoma relevant translocations from
antigen receptor genes. Using ATAC-seq, which measures chromosomal accessibility via Tn5 transposase
insertion, we observed temporal changes of local accessibility around DSBs and, surprisingly, polarization of
global accessibility in regions distant from the targeted breaks: increases accessibility of accessible regions and
decrease the accessibility of non-accessible regions in a 53BP1-dependent manner. And the high accessibility
regions are also at risk for additional breaks measured by End-Seq and chromosomal translocations measured
by HTGTS. Since ATM phosphorylates histone H2AX and 53BP1 to promotes their recruitment to nucleosome
occupied regions, we hypothesize that DNA damage response leads to redistribution of the chromatin
bounded factors (e.g. 53BP1) based on nucleosome density and contribute to cell type specific genomic
instability (breaks and translocations) and malignancies. To test this, we will 1) address the molecular
mechanisms by which ATM mediated DNA damage response regulates the pattern and outcome of
chromosomal translocations during the assembly and modification of antigen receptor gene products and during
lymphomagenesis, 2) characterize the impact of cell cycle phases (G1, G2, proliferating) on translocation pattern,
and 3) elucidate the translocation outcome of different type of breaks – clean breaks, RAG or AID initiated
breaks and replication stress induced lesions. In collaboration with others in the P01, we will integrate the
damage induced accessibility changes with substitution and rearrangement signatures (Project 1 & 2), cell cycle
(Project 2 & 4) and 3D organization (Project 4). By comparing the signatures from ATM-deficient vs BRCA1-
deficient (Project 1) cells, the results will shed lights on how loss of these two major tumor suppressors cause
different genomic instability signatures and eventually lead to tissue/organ specific malignancies.

Public health relevance
PROJECT NARRATIVE Our proposed study 1) addresses the molecular mechanisms by which DNA damage responses affect the substitution and translocation signatures during lymphomagenesis, 2) identifies the impact of cell cycle phases on the DNA damage induced accessibility changes and the translocation patterns, and 3) elucidates the translocation outcomes of different type of breaks – clean breaks, RAG or AID initiated physiological break in antigen receptor genes, and Top1-cc like lesions.